ANESTHETIC MECHANISMS IN GABA--R GENE TARGETED MICE

DESCRIPTION: (Adapted from the applicant's abstract) This study aims to elucidate the molecular target(s) of anesthetic action by creating knockout mice and examining the progeny for sensitivity to inhaled anesthetics. Six genetically altered mouse lines carrying mutations at GABAA receptor loci are proposed, specifically null alleles of a6, b3, g2, d subtypes, as well as point mutations of a6 and g2 subunits. These specific alleles have been chosen since inbred mice missing these alleles or carrying specific mutations have been shown previously to have altered sensitivity to anesthetic agents. After creation of the mouse strains, each will be tested for anesthetic sensitivity (5 volatile GAs on tail clamp/withdrawal MAC, loss of righting reflex), chloride flux experiments from brains of bred mice, and finally electrophysiologic studies to determine if single mutations change other neurons as well as characteristics of the channel with and without anesthetics. Hence behavioral and electrophysiology data are the endpoints of this project.